Data Coordinating Center for the Type 1 Diabetes in Acute Pancreatitis Consortium

PROJECT SUMMARY / ABSTRACT
According to recent reports, pancreatogenic DM, a known complication of acute pancreatitis, may occur more
frequently than previously recognized. Currently, limited data exist on well-phenotyped post-AP subjects from
prospective studies to confirm this information. The Type 1 Diabetes in Acute Pancreatitis Consortium (T1DAPC)
was formed in 2020 to fulfill this knowledge gap (RFA-DK-19-023). The primary longitudinal study of the T1DAPC
is the DREAM study which is funded and will begin enrolling patients in September 2021. The IMMINENT study
is being proposed as the imaging biomarker arm of the DREAM study. Patients who experienced AP will enroll
in the DREAM study and a subset of those participants will enroll in the IMMINENT study to have serial MRI
examinations at 3, 12, 24 and 33 months. Preliminary data suggest that certain features on MRI not currently
used in clinical practice can be useful in risk the assessment of DM. The hypothesis of the IMMINENT is that by
identifying parenchymal changes in post-AP patients, MR imaging can differentiate at-risk individuals from those
who will remain euglycemic. To achieve this goal, we will use several quantitative MR imaging techniques to
interrogate the parenchyma. In addition to the advanced MRI analysis, we will use artificial intelligence and deep
learning algorithms to detect changes that are not visible to the human eye. Our purpose is to observe and
understand the natural history of DM after AP and demonstrate that MR imaging can reflect underlying
pathophysiologic changes and serve as a biomarker of DM. We believe data generated from IMMINENT will
enhance our understanding of the pathogenesis of post-AP DM. If successful, we will develop a quantitative
composite risk score using useful MRI features. This composite risk score can be used for monitoring the risk of
metabolic dysfunction in practice or clinical trials. As part of the T1DAPC (a multicenter collaborative network),
we propose an excellent opportunity to investigate the post-AP DM by incorporating dedicated pancreas
radiologists, gastroenterologists, endocrinologists, a data coordinating center, MR image analysis, and AI labs.

Public health relevance
PROJECT NARRATIVE According to the NIDDK RFA-DK-21-501, pancreatic imaging is an essential tool in the early diagnosis and staging of pancreatic disease and has been used recently to detect significant atrophy in the pancreas of people with diabetes mellitus (DM) as well as increased fat content in patients. The IMaging Morphology of Pancreas in DIabetic PatieNts following AcutE PaNcreaTitis (IMMINENT) study is the imaging biomarker arm of the Type 1 Diabetes in Acute Pancreatitis Consortium (T1DAPC) primary study, the Diabetes RElated to Acute pancreatitis and its Mechanisms (DREAM). The IMMINENT study will observe and define the natural evolution of pre-DM and DM by evaluating the serial magnetic resonance imaging (MRIs) using quantitative MRI metrics as non- invasive imaging biomarker for the evolution of acute pancreatitis-associated DM, utilizing quantitative MR imaging features, deep learning algorithms and artificial intelligence (AI) tools to assess changes in the pancreas, and correlating MRI metrics with DREAM phenotypes for risk stratification.